The purpose of this procurement is to obtain annual population estimates for counties and census tracts based on the counts produced by the US Census Bureau.

The purpose of this procurement is to obtain annual population estimates for counties and census tracts based on the counts produced by the US Census Bureau.